INnovative data Science to Impact the TB Epidemic - INSITE

There are limited opportunities in Africa to work with routine clinical and health data at
scale, and to develop the expertise to process these data in an environment in which
both the burden of disease and the approach to enumeration and coding are very
different to other settings where routine data are exploited for epidemiological analyses.
Tuberculosis disease (TB) is the most important HIV-associated comorbidity in South
Africa and the leading cause of death in people living with HIV (PLH). Maternal TB
(pregnancy and postpartum period) deleteriously affects morbidity and mortality in
women and infants. Pregnancy outcomes are worse, exacerbated by HIV co-infection
which is present in 60%, and there is increased risk of perinatal TB and HIV
transmission. Rifampicin-resistant (RR)-TB with/without fluoroquinolone resistance is a
growing global public health concern with prevalence rates at 4.2% of TB cases in the
Western Cape Province, South Africa. South Africa was prompt to include novel and
repurposed second-line therapeutic agents against RR-TB in routine guidelines,
including pregnant and breastfeeding women. The safety of these agents during
pregnancy and lactation is uncertain but the rising incidence of RR-TB has seen the use
of these agents during pregnancy at scale. The concomitant use of antiretroviral therapy
(ART) for HIV treatment raises concerns about potential drug-drug interactions with
safety and efficacy implications. Maternal TB remains under-prioritized globally despite
the burden of HIV and TB in those of child-bearing age. In this context of high infectious
burden in which novel/repurposed anti-mycobacterial agents for the prevention and
treatment of TB are used at scale during pregnancy, often co-administered with ART, the
Western Cape is uniquely positioned in hosting the Provincial Health Data Centre
(PHDC), the first comprehensive linked health information exchange in Africa. The
PHDC leverages the use of a province-wide unique patient identifier issued to users of
the health services to harmonise all electronic health data from routine health
information systems in public sector facilities, including laboratory, pharmacy,
administrative and other clinical data. These data are integrated and curated to enable
inference of health conditions using phenotype algorithms, as well as to enable the
consolidation of co-morbidities and construction of patient-level cascades that can be
used to monitor and analyse health service utilisation patterns and healthcare outcomes.
The partnership between the Centre for Infectious Disease Epidemiology & Research,
University of Cape Town and the Health Intelligence Directorate of the Western Cape
Government which houses the PHDC offers a unique opportunity to develop and
evaluate a robust maternal TB data platform, using data science to i) create actionable
clinical tools to optimize person-level interventions and monitor programs; ii) generate
large, linked cohorts to address the epidemiological questions of maternal TB and
assess the impact of policy interventions and clinical tools at the population and
individual levels.

Public health relevance
New drugs and shortened combination regimens have been introduced for the prevention and treatment drug- susceptible and drug-resistant tuberculosis (TB) but their impact on pregnant women and their infants, including TB transmission and pediatric TB, is uncertain. This partnership between the Centre for Infectious Disease Epidemiology & Research, University of Cape Town and the Western Cape Health Intelligence Directorate will consolidate existing relationships across clinical, epidemiological and data science disciplines to establish a scalable data infrastructure for the management of maternal TB at the regional and individual clinical levels. Data science techniques will be employed to develop and enhance a novel and robust public service population-level data harmonization platform to i) create actionable clinical tools to optimize person-level interventions and monitor programs; ii) generate large, linked cohorts to address epidemiological questions and assess the impact of policy interventions and clinical tools at the population and individual levels.